Developing novel nanobody-based biosensors and therapeutics for Huntington’s Disease

PROJECT SUMMARY
Misfolding and aggregation of mutant huntingtin exon1 (mHTTex1) promotes neurodegeneration in Huntington’s
disease (HD). The intrinsically disordered mHTTex1 misfolds into a heterogeneous mixture of assemblies,
however, how they form, and which conformers mediate neurotoxicity in vivo remain to be identified. This gap in
knowledge is due to a lack of molecular diagnostic tools to study the oligomerization pathway of native mHTTex1
in live neurons and to determine how it may induce neurodegeneration. Conformer-specific nanobodies will
enable us to perform these studies. Nanobodies are genetically encoded variable heavy domains (VHH), which
are naturally produced by camelids and sharks and display potent specificity towards target antigens. This project
will combine the experience of Dr. Langen’s lab in generating defined and stable helical oligomers and protofibrils
of recombinant mHTTex1, with the that of Dr. Khoshnan’s lab in nanobody technology and its application to
studies on the neurobiology of mHTTex1. We recently reported that among the various assemblies of
recombinant mHTTex1, protofibrils and their precursors helical oligomers are neuroinvasive since they can
penetrate human neurons, propagate, and induce nuclear damage. Towards identifying similar conformers in
vivo, we now have isolated llama nanobodies, which bind to helical oligomers, and protofibrils of recombinant
mHTTex1. We plan to investigate the binding properties of these nanobodies and develop diagnostic tools like
chromobodies by fusing them to GFP or RFP. These biosensors will be used to study the early steps of native
mHTTex1 oligomerization in live human neuronal stem-cell derived neurons, and examine whether helical
oligomers and/or protofibrils are neurotoxic. Nanobodies, which may inhibit the oligomerization of mHTTex1, will
be tested for ability to prevent aggregation and toxicity in the same model. This project has the potential to make
a significant contribution to our understanding of mHTTex1 oligomerization and neurotoxicity in a physiologically
relevant model, identify therapeutic modalities, and provide a set of novel molecular diagnostic tools for the
broader HD research community.

Public health relevance
NARRATIVE This proposal will produce a collection of novel nanobodies to neurotoxic assemblies of mutant huntingtin exon1 and engineer chromobodies to identify similar conformers in live neurons and identify nanobodies, which block their formation. These studies will provide valuable knowledge on the pathogenic conformers of mutant huntingtin and produce novel diagnostic biosensors and potential therapeutics for target-specific intervention in HD.